Analysis of complex biological systems by high-throughput genomic technologies

The Computational Biology & Genomics Core (CBGC) aims to advance aging research at NIA-IRP through the analysis of complex biological systems using high-throughput genomic technologies such as next-generation sequencing, long-read sequencing, single-cell sequencing, and spatial transcriptomics. CBGC primarily provides these services to NIA intramural scientists and their collaborators. Additionally, we collaborate directly with investigators from other NIH institutes and the extramural community. In the past year, we have completed sequencing of over 2,500 samples using Illumina sequencers, over 200 samples with the Oxford Nanopore PromethION long-read sequencer, and 250 10X Genomics Single-Cell sequencing samples. The Computational Biology & Genomics Core offers comprehensive support, including advice on experimental design and sample preparation, quality control of samples, data analysis, data sharing, and training. While our primary focus is on genomic and transcriptomic research, we are also highly involved in applying Artificial Intelligence (AI) for image analysis, spatial transcriptomics analysis, and novel multi-omics data analysis algorithms. On average, CBGC arranges 12 seminars and classes each year, providing over 30 days of training to more than 500 NIA-IRP staff. To meet the needs of NIA IRP researchers, we utilize Illumina and Oxford Nanopore sequencers, 10x Genomics single-cell and spatial transcriptomics analysis instruments, as well as the MERSCOPE spatial transcriptomics instrument. Moreover, CBGC maintains several high-performance computer systems and large GPU servers for AI-based data analysis. We are also involved in designing and maintaining NIA IRP cloud computing services, which are available to all interested NIA IRP researchers.